Scientific Communication Advances Research Excellence (SCOARE) 2.0

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Project Summary
The objective of the proposed program renewal is to develop capacity of biomedical research trainees and their commitment to research careers by providing their mentors with linguistically informed and evidence-based knowledge, skills, and resources for mentoring scientific communication (SciComm). “SCOARE 2.0” builds on the existing program “Scientific Communication Advances Research Excellence” (NIH-NIGMS,
R25GM125640, 2017-2022), and will expand its reach, augment its curriculum, and ensure its sustainability. Formal evaluations and preliminary research findings of the original SCOARE program suggest that providing mentors with the relevant knowledge and skills about SciComm development results in a variety of important and measurable benefits for their mentees and themselves. The specific aims of SCOARE 2.0 are to 1)
Broaden availability of the existing SCOARE workshops and facilitator training; 2) Adapt the workshop for future-faculty audiences and add new modules that provide deep dives on giving quality feedback and on the use of artificial intelligence tools; 3) Increase impact and sustainability of the program by translating it to a hybrid asynchronous format. The expected outcomes for this program include continued delivery of the existing face-to-face program nationally to a minimum of 300 participants (faculty, administrators, and future faculty) as well as train approximately 80 new facilitators; development and delivery of the new content modules; development and launch of an enduring asynchronous version of the workshops, freely available online; and external evaluation of all new components. The innovation of the work is that it is grounded in linguistic and social-cognitive evidence that leverages the powerful links between language, motivation, and professional identity and that, to our knowledge, it is the first mentor training curriculum to address SciComm skill development and its deeper influence on mentee career intentions. The impact of this program will be to help mentors build a research workforce possessing superior training and high professional commitment, thus aligning with the NIH’s goals providing a return on its investment. The investigators are ideally positioned to carry out this project because of their experience collaborating on the design, delivery, and evaluation of the existing SCOARE program.

Public health relevance
Project Narrative The “Scientific Communication Advances Research Excellence 2.0” program (SCOARE 2.0) is relevant to public health because it will contribute to building and sustaining a highly skilled biomedical and behavioral research workforce. The program will continue to provide innovative, evidence-based mentor training in the principles and practices of scientific communication (SciComm) skill development and broaden its impact through the addition of novel content and translation to a hybrid asynchronous delivery format. The SCOARE 2.0 program is relevant to the NIH goal of supporting educational activities that complement and/or enhance the training of a research workforce meeting the nation’s biomedical, behavioral and clinical research needs.